Perception of Dysarthric Speech

DESCRIPTION (provided by applicant): Reduced intelligibility is at the heart of the communication disorder associated with the dysarthrias and other speech production deficits, undermining quality of life. This research program aims to develop a comprehensive model of intelligibility deficits that offers an explanation for communication failure and success, and thereby identifies targets for remediation, as well as dependent variables that will serve as outcome measures. We have shown that when listeners encounter speech that is difficult to understand, they turn their attention to prosody to help them decide where words begin and end. However this strategy for lexical segmentation becomes challenged when the prosodic information itself is degraded, as in the dysarthrias. Further, the nature of the prosodic degradation predicts the ways in which word boundary identification is impaired. The differences in perceptual error patterns resulting from speech produced by two equally intelligible speakers are predictable and provide information both about the underlying motor deficit and the perceptual representations and strategies of the listener. The present proposal defines this relationship through the development of sensitive dependent variables that predict listener performance patterns and production characteristics. Specifically, we will refine a set of acoustic measures and establish their predictive relationship to perceptual performance (intelligibility and error patterns), using speakers with dysarthria and healthy controls. These automated acoustic measures include measures of based on the low-frequency modulations of the amplitude envelope and measures of fundamental frequency and average spectral variability. This set of acoustic measures will be used to classify speakers by traditional dysarthric subtypes as well as by groupings based on a perceptual-outcome clustering that will be developed using the error patterns obtained from listeners' transcription of each speaker's samples. The model will be tested and refined on a new more diverse group of speakers with intelligibility deficits. The causality of the relationships between acoustics and perception uncovered by these analyses will be tested through perceptual experiments using speech samples that are digitally manipulated to match the prosodic patterns that are associated with particular error types. The proposed project holds promise for immediate clinical impact by providing both sensitive and meaningful outcome measures and an overarching theoretical framework in which to interpret them.

Public health relevance
PUBLIC HEALTH RELEVANCE: The overall goal of the current project is to develop a theoretically-derived model of intelligibility deficits that has immediate clinical impact by identifying targets for remediation and offering dependent variables that may be used to predict perceptual outcome and track changes in speech due to intervention or disease progression. By defining a set of objective measures that map to meaningful aspects of speech understanding, these dependent variables can be applied to any communication disorder for which intelligibility is reduced. Project Narrative/Relevance The overall goal of the current project is to develop a theoretically-derived model of intelligibility deficits that has immediate clinical impact by identifying targets for remediation and offering dependent variables that may be used to predict perceptual outcome and track changes in speech due to intervention or disease progression. By defining a set of objective measures that map to meaningful aspects of speech understanding, these dependent variables can be applied to any communication disorder for which intelligibility is reduced. __SpecificAimsTextDelimiter__ Specific Aims Our research program has been designed to develop a model of intelligibility deficits associated with the dysarthrias, with application to degraded speech in general. In particular, we have investigated those perturbations of the speech signal that are most deleterious to the listeners' accurate comprehension of the intended message. Our work has produced converging evidence that listeners rely heavily on prosodic information to aid in the comprehension of degraded speech. Key to this finding is that listeners commonly apply the cognitive-perceptual strategy of relying on prosodic information to identify word boundaries when encountering a speech signal that contains impoverished segmental information. That is, when there is sufficient uncertainty about the identity of phonemes in connected speech, listeners shift their attention to prosodic cues to make predictions about where words begin and end (lexical segmentation). Phonemic ambiguities are then resolved within these word-delimited frames. When listeners are faced with degraded speech that has reduced or abnormal prosodic variation-as in the case of the dysarthrias-their ability to use this information to facilitate lexical segmentation is challenged. Failure to properly segment the signal is difficult to overcome and typically leads to radical changes in the perceived message. Perhaps the most crucial observation from our work is that the different forms of impaired prosody (for example, across dysarthria subtypes) result in different patterns of perceptual outcomes (lexical boundary errors). In this way, not all intelligibility deficits are created equal. The differences in perceptual error patterns resulting from speech produced by two equally unintelligible speakers is predictable and provides information both about the underlying motor deficit and the perceptual representations and strategies of the listener. In order to investigate these relationships of signal disruptions and intelligibility, we have performed extensive acoustic analyses on speech produced by a variety of speakers with dysarthria, and have examined the perceptual error patterns obtained from normal-hearing listeners presented dysarthric speech and non-dysarthric speech that has been digitally altered to match some of the acoustic characteristics that we have measured in dysarthric speech. This multi-pronged approach is necessary to achieve our ultimate goal: a predictive/explanatory model of intelligibility deficits that ties specific acoustic measures to particular motor deficits of the speaker (or degradations of the signal in the environment) and to particular representations and challenges for the listener. Our work, to date, has established that error patterns by listeners are, in fact, predictable from the subtypes of dysarthria and the listeners' comprehension strategies. We have also detailed a number of candidate acoustic measures that appear to mediate the relationship between production deficit and comprehension deficit. In the current project we will develop the most promising acoustic measures and test their ability to predict intelligibility and error patterns for speech produced by talkers from a greater range of typicality and severity. We will also explicitly test the explanatory power of our findings by through stimulus manipulation in controlled perceptual experiments. Specific aims for this project are as follows: Specific Aim #1: [Refine a set of supra-segmental acoustic measures and test their ability to capture the nature of speech deficits by speakers with dysarthria and predict the level of intelligibility and error patterns for listeners]. The first set of experiments will capitalize on the large database of speech samples collected over our previous NIH-funded work. This database includes single-word, sentence, spontaneous and read passage samples from 102 speakers with neurological disease and concomitant dysarthria. We will analyze these samples using a variety of dependent measures that quantify i) the average spectral energy and variability in energy around this average in different frequency bands; ii) mean and variability of fundamental frequency and iii) speech rhythmicity. The rhythmicity measures include variables obtained from the modulation spectrum for amplitude envelopes extracted from the full signal and for filtered octave bands. To date, we have found that subsets of the rhythmicity measures are remarkably predictive (accounting for over 80% of the variance) of that speaker's intelligibility on another group of sentences. Various constellations of the measures also achieve high classification accuracy for dysarthria type, and others predict patterns of lexical boundary errors within even narrow ranges of intelligibility. We will further test the utility of these three sets of measures as correlates of particular production deficits and of perceptual error rates using the larger and more variable total database with the addition of samples taken from an age and gender matched control group. We will also use cluster and principal components analyses to derive an optimal classification scheme of talkers based on patterns of listener errors and examine how well our acoustic measures predict these perceptually-relevant clusters. These experiments will establish functions (from discriminant and regression analyses) that optimally predict, 1) traditional dysarthric subtype, 2) overall intelligibility, 3)specific measures of error type (e.g., vowel errors, lexical boundary errors, word substitution errors) and 4) perceptually-relevant classifications based on listener error patterns. Specific Aim #2: [To test the predictive utility of our model and acoustic measures on a novel sample of talkers with production disorders that varies more widely in severity and representativeness of traditional subtypes.] One potential benefit of an explanatory model of intelligibility that incorporates variability from speaker, acoustics, and listener is the ability to predict error patterns and challenges for communication from relatively simple acoustic measures. The dysarthric speaker database (to be analyzed in Aim 1) consists of samples chosen because they are representative of the characteristics associated with the traditional dysarthric subtypes (Darley et al., 1969). These constraints were necessary in our previous design to make clear predictions about perceptual outcomes based on subtype and to test the claim that listener error patterns were qualitatively different (and predictable) even for talkers with equal overall intelligibility. However, the utility of our approach is dependent on our model being applicable to a much more variable population of speakers, especially those who may be difficult to classify using traditional schemes. Our efforts to connect acoustic measures with their perceptual consequences should allow us to predict outcomes even for speakers who are unlike our original sample. Our 2nd specific aim is to explicitly test our ability to predict perceptual outcomes from a new and diverse sample of dysarthric speech. We will record productions from a novel sample of talkers from our clinical population and evaluate whether we can determine subtype classification and predict intelligibility and listener error patterns using the functions and classification schemes that we will derive from our current database of typical speaker productions (Aim #1). This aim will incorporate the classification analysis (Aim 1) as well as the collection and analysis of perceptual data from groups of healthy listeners. Specific Aim #3: [Test the explanatory model of how the acoustic dependent variables interact with listener strategies to result in particular intelligibility deficits.] To achieve a comprehensive model of intelligibility deficits and to motivate targets for remediation, it is necessary to understand how manipulations of listener variables and signal characteristics cause changes in perceptual performance. Our previous work has demonstrated that listeners are put at a disadvantage when listening to dysarthric speech because the perturbations in f0, spectral variability and rhythm lead to inaccurate lexical segmentation with the default listening strategy. We will further develop this perceptual model using our new sets of acoustic measures to predict specific patterns of lexical segmentation and word substitution errors by direct manipulation of listener and speech signal variables. This aim will be accomplished by two types of perceptual experiments: a. Perceptual Learning Tasks: The central hypothesis of our current model is that listeners have expectations about the duration and timing of speech events (e.g., syllables or word boundaries) and that these expectations can change as listeners have experience with systematic rhythm-f0 patterns. We will test this hypothesis and its attendant predictions (e.g., samples of hyperkinetic dysarthric speech with near-random variations in rhythm will provide less opportunity for learning) using perceptual learning paradigms that we have developed in the previous NIH funded period. Listeners will be presented sentences either grouped by having common rhythm metrics (e.g., same dysarthria subtype or rhythmic group determined from clustering in Aim #2) or grouped randomly. In another set of experiments, we will systematically vary exposure type and duration to define the flexibility of the perceptual system in adjusting to differences and variation in speech rhythmicity. b. Digital Manipulation of Normal Speech Samples: As part of Aim #1 we will measure the correlations of our acoustic measures with perceptual error patterns. In order to examine the causation of these relations for Aim #3, we will digitally manipulate perfectly intelligible speech samples to match high-low values on the acoustic measures and test whether similar patterns of perceptual errors can be obtained. We will manipulate spectral variability, fundamental frequency contours and amplitude envelope characteristics within specified frequency bands using well-established digital signal processing techniques. In our view, the strengths of the current proposal include 1) the translational nature of the work in which speech perception theory and clinical practice mutually inform each other in the development of a model of speech intelligibility deficits, and 2) the paradigm shift that shows promise for recasting the ways in which intelligibility deficits are conceptualized, including new explanatory classification schemes that transcend traditional disorder type boundaries. The scope of the specific aims requires a dual PI model incorporating clinical and theoretical expertise in speech production, acoustics and perception. It is expected that this project will establish an overarching framework that accounts for and predicts the communication disability in the dysarthrias and can be easily extended to other conditions of communication deficit due to a degraded signal.